NUTRITION IN TEENS (SONIT)

This protocol will evaluate the consumption of beef versus chicken and fish in a clinical study of lipid reduction through diet among adolescents in the Iowa City school system.